Research Training on HIV Prevention and Treatment in Children and Adolescents (UO

ABSTRACT
Adolescent girls and young women represent the fastest growing population of persons living with HIV in Kenya,
contributing nearly 40% of new HIV infections. This pattern jeopardizes efforts to address HIV in infants and
contributes to the sustained epidemic of pediatric HIV. Kenya had impressive gains in preventing vertical HIV
transmission in the early years of the epidemic, however these gains have been reversed in recent years and
Kenya’s current vertical HIV transmission rate of >8% is unacceptably high. In Kenya, clinician-scientists played
a major role in anchoring the early HIV response yet there are limited opportunities for career development in
Kenya for individuals with a clinical background who wish to continue in clinical practice and teaching while
building a research career in an academic setting. The majority of successful Kenyan clinician-scientists have
been trained overseas, highlighting the need to develop and scale-up research-oriented training programs in
Kenya. This application therefore seeks to strengthen the research training opportunities in Kenya for clinicians
who want to develop careers as independent researchers through the proposed program, “Research Training
on HIV Prevention and Treatment in Children and Adolescents.” The program will be led by Drs. Dalton Wamalwa
and Ruth Nduati at the University of Nairobi (UoN) and co-directed with Dr. Carey Farquhar at University of
Washington (UW), Bernard Awuonda at Maseno University (MU) and Kenneth Ngure at Jomo Kenyatta
University of Agriculture and Technology (JKUAT). The program will offer long-term training which includes
doctoral-level training in Epidemiology (5 trainees) and in Biostatistics (1 trainee) at UoN (3-4 years) and master’s
level training in biostatistics (1 trainee) in Seattle (1.5 years). The program will also offer a 15-week synchronous
online Advanced Certificate in Research to clinicians at UoN, MU and JKUAT (doctors, nurses and pharmacists)
in master’s programs with an interest in pediatric and adolescent HIV (75 per year, 300 total), as well as a
combination of in-person advanced short courses and workshops conducted in collaboration with partner
institutions. The Principal Investigators have substantial experience with Fogarty training programs and other
training programs based in Kenya. They will work closely with members of a Steering Committee with
representatives from all 4 institutions and an external Training Advisory Committee (TAC) to ensure success of
each trainee and the overall program. Together, all the partners and the extensive network of faculty will work
towards a goal of strengthening evidence-based approaches to prevent and treat pediatric and adolescent HIV
and conduct locally relevant research in Kenya.

Public health relevance
PROJECT NARRATIVE The proposed program, “Research Training on HIV Prevention and Treatment in Children and Adolescents,” will build research capacity in Kenya for emerging health professionals with clinical backgrounds who wish to continue in clinical practice as well as build a research career in academic settings. The University of Nairobi (UoN) will collaborate with the University of Washington (UW), providing training to improve capacity in epidemiology and biostatistics, towards a goal of strengthening evidence-based approaches to prevent and treat pediatric and adolescent HIV and conduct locally relevant research in Kenya.